Training in Learning and Memory

PROJECT SUMMARY/ABSTRACT
The Center for Learning and Memory (CLM) at the University of Texas at Austin brings together researchers
whose goal is to identify the neural mechanisms that support learning and memory. The CLM has grown to
include eighteen faculty since its inception in 2004. The highly interdisciplinary and collaborative nature of the
CLM faculty provide the key elements for an innovative and active training program in learning and memory. The
CLM faculty represent a broad range of approaches to the mechanisms of learning and memory – from the
molecules of neural signaling and synaptic plasticity to cellular and systems level studies to functional
neuroimaging in humans. We will leverage the strengths of this collaborative faculty to provide structured training
in rigorous research design and methodologies, state-of-the-art quantitative approaches, and professional
development training activities to prepare graduate students and postdoctoral trainees to become innovative
leaders in the field of learning and memory research. The proposed training will support four predoctoral and two
postdoctoral trainees each year. Trainees are expected to be appointed to the training program for no more than
3 years before transitioning to individual grants and fellowships. The proposed training has four important
components. First, we will provide our trainees with hands-on instruction in the implementation of interdisciplinary
approaches to the study of learning and memory that cross levels of analysis. Second, we will provide extensive
training in advanced statistical and computational neuroscience methods that are increasingly necessary to
understanding the neural mechanisms that support learning and memory. Third, the proposed activities will
provide our trainees with the ability to place their research in a biomedical context, with an emphasis on the role
of learning and memory processes in disorders of mental health. Finally, the proposed activities and resources
provide our trainees with many opportunities for career development, including the skills necessary to obtain a
tenure track position (e.g., presentation and grant writing skills) as well as research-related careers outside of
academia. These components will prepare our trainees to be the next generation of leading-edge researchers
dedicated to understanding the neurobiological mechanisms of learning and memory and how they are impacted
in disorders of mental health.

Public health relevance
PROJECT NARRATIVE Impairments in learning and memory are characteristic of several mental health disorders, including schizophrenia, depression, and post-traumatic stress disorder. As such, there remains an urgent need to understand the brain mechanisms that underlie learning and memory in an effort to aid the development of effective treatment interventions for psychiatric and neurological disorders that require acquisition and maintenance of new behaviors. This program will provide predoctoral and postdoctoral trainees with training in advanced methods used to study learning and memory, including cross-disciplinary experimental approaches, advanced statistical analyses, and computational modeling.